Project 2

Project 2 Abstract
The overarching goal of Project 2 is to optimize peer coaching in order to optimize engagement and outcomes
in digital therapy. The unmet mental health needs of community college students are staggering and a growing
body of research demonstrates that therapy provided digitally with the assistance of trained community
members without advanced degrees in mental health is an effective and scalable way to address these needs.
Despite being effective for improving symptoms and functioning in those who engage in it, uptake and
engagement in digital therapy is generally quite low. Recent research suggests that this is especially true of
Latinx individuals, who tend to have unique and significant unmet mental health needs. To address these issues,
Project 2 will examine treatment engagement, treatment satisfaction, symptoms, and functioning outcomes
among Latinx students at East Los Angeles College (ELAC) receiving digital therapy with peer coaching in the
STAND program. ELAC is a large and diverse community college that is predominantly Latinx. A sample of 240
ELAC students who identify as Latinx will be independently recruited, separate from the Signature Project. A
2x2 design will randomize ELAC students to one of four peer coaching conditions (n = 60 per condition): 1)
demographic matching + standard supervision, 2) demographic matching + reduced supervision, 3) no
demographic matching + standard supervision, and 4) no demographic matching + reduced supervision.
Students in the demographic matching condition will be assigned to peer coaches who also identify as Latinx,
whereas those in the no demographic matching condition will be assigned to peer coaches who do not identify
as Latinx. Supervision will either involve individual session review and personalized feedback or not. Students
will participate in this project for 24 weeks and will complete brief weekly assessment batteries and longer
assessment batteries at baseline and at weeks 8, 16, and 24. Explanatory/intervening variables that are
hypothesized to explain treatment effects will also be explored. In addition to the quantitative data collected
from the RCT, we will collect and analyze qualitative data from the peer coaches via annual focus groups and
will evaluate cost-effectiveness specifically focused on costs related to supervision. Combined, these data will
inform the iterative refinements made to Tier II in the Signature Project, and will significant gaps in the literature
regarding demographic matching, clinical supervision, and mental health disparities experienced by Latinx
individuals, particularly as they relate to the developing field of digital mental health.